Planning and Evaluation

PROJECT SUMMARY (See instructions): Planning and Evaluation (P&E) is a continuous, coordinated and cohesive process that strives to: 1) set the strategic vision of the Cancer Center; 2) identify and foster the development of new initiatives; and 3) evaluate and improve Research Programs, Shared Resources and other relevant activities.

Public health relevance
P&E plays a critical role in integrating the expertise and talent of the diverse DF/HCC community and promoting synergy among DF/HCC Programs and individual members.